PROTEIN PATTERNS IN LEUKEMIC CELLS

The project examines the contribution of Op18 and hsp27 to leukemogenesis in childhood leukemia. The relationship between expression and severity of the disease is being sought.